Improving Quality of Life and Behavioral Health Service Access for Caregivers and Young Children after Pediatric Traumatic Injury

Interventions that address families’ quality of life and emotional and behavioral needs after pediatric traumatic
injury (PTI) are a public health priority, with nearly 120,000 children hospitalized annually for severe injuries.
PTI is associated with annual individual and societal costs of $87 billion and elevates risk for posttraumatic
stress disorder (PTSD), depression, and other health risk consequences that affect quality of life, physical
recovery, family roles and routines, and academic functioning. Caregivers are a key source of support for
preadolescent children following PTI, and caregivers’ emotional health is highly correlated with children’s
outcomes. One in three children endorse PTSD and/or depression symptoms after PTI, and over 50% of
caregivers develop high distress and significant PTSD symptoms. Therefore, interventions targeting caregiver
and young child distress that have high potential for uptake in pediatric trauma centers are critically needed.
Pediatric trauma centers recognize the need to support behavioral recovery, particularly in response to the
American College of Surgeons’ 2022 guidelines to provide mental health screening and intervention to trauma
patients at high risk. However, no clear roadmap exists for these centers to support emotional recovery and
established, scalable and sustainable models of care are lacking. We are in the final stages of an NICHD K23
where we are piloting CAARE (Caregivers’ Aid to Accelerate Recovery after pediatric Emergencies), a
technology-assisted, stepped care intervention informed directly by patients and caregivers after PTI that
provides children under age 12 and their caregivers: (1) inpatient emotional and behavioral screening and
education, (2) brief inpatient risk reduction intervention, (3) mHealth-facilitated symptom self-monitoring and
coping tools, and (4) 30-day evidence-based treatment referrals for families who need it. CAARE was well
received by caregivers and providers, with pilot data indicating that this model is appealing to caregivers and
has high potential to address service barriers by providing real-time assistance to help caregivers manage their
own distress and their children’s behavioral recovery. We now propose to conduct a hybrid effectiveness-
implementation trial to examine the extent to which CAARE improves children’s and caregivers’ quality of life,
clinical and functional health outcomes, and follow-up treatment engagement and to inform widescale
implementation of CAARE. We will conduct a randomized controlled trial with 348 families randomly assigned
to CAARE (n=174) vs. enhanced usual care (n=174). Caregivers of children under age 12 hospitalized for
traumatic injury will be recruited and assessed by independent, blind evaluators at baseline, 3-, 6-, and 12-
months. We will assess CAARE acceptability, feasibility, and appropriateness and identify barriers and
facilitators that influence implementation, sustainability, and ability to equitably address the needs of families
from underrepresented racial, ethnic, and trauma groups. The ultimate goal of this line of work is to achieve
population-level impact in U.S. pediatric trauma centers through enhanced service quality, reach, and equity.

Public health relevance
PROJECT NARRATIVE Pediatric traumatic injury (PTI) is a public health priority, with more than 125,000 children experiencing injuries that require hospitalization each year. These children, and their caregivers, are affected in many ways that may affect quality of life, emotional and behavioral health, physical recovery, family roles and routines, and academic functioning; yet US trauma centers do not adequately address these outcomes and a scalable national model of care for these families is needed. This proposal builds on evidence from an NICHD K23 to test a technology-assisted, stepped care behavioral health intervention for children (<12 years) and their caregivers after PTI, CAARE (Caregivers’ Aid to Accelerate Recovery after pediatric Emergencies), via a hybrid type I effectiveness-implementation trial with 348 families randomly assigned to CAARE (n=174) vs. guideline-adherent enhanced usual care (EUC) (n=174).